Development of an innovative neurosurgical planning tool for awake craniotomy

SUMMARY/ABSTRACT
Brain tumors result in a disproportionate rate of cancer morbidity and mortality. Standard of care treatment
includes maximal safe surgical resection, with extent of surgical resection (EOR) representing the most relevant
prognostic factor for patient survival. Because EOR is dependent on the surgeon’s capability to distinguish
between healthy brain tissue and tumor-invaded tissue in or adjacent to brain areas that support cognitive
function, the neurosurgeon must balance clinical objectives against causing cognitive impairments. The ground
truth standard-of-care procedure to facilitate this distinction is awake craniotomy with brain mapping using direct
electrical stimulation mapping (DES). Knowing the location of specific functions with respect to real-time surgical
targets allows the clinical team to protect those functions. However, there is no evidenced-based platform that
allows clinical teams to choose the most sensitive task to map and measure a given brain region, or to
understand the implications for future cognitive function of removing a specific volume of brain tissue. To fill this
gap, MindTrace Technologies, Inc. is developing a cloud-based software platform to be used before, during, and
after a neurosurgical procedure to improve the process of evaluating and choosing an optimal treatment plan.
The MindTrace platform supports the administration of functional brain mapping protocols (functional
neuroimaging, DES mapping), and the pre-processing and co-registration of behavioral and neural data in the
service of optimizing the effectiveness of brain mapping during awake brain surgery. The goal of this Direct to
Phase II SBIR proposal is to further improve the advanced prototype MindTrace software platform and deploy it
under IRB in the context of a research study to collect prospective longitudinal data at 4 major medical centers.
Completion of these Aims will result in a commercializable product and lay the empirical and technological
foundation for the development of real-time AI-based predictive analytics, a large-scale clinical trial, and FDA
clearance. The design of the proposed protocol is based on written feedback from FDA (qSub meeting) regarding
the parameters of a dataset needed for successfully apply for Breakthrough Device Designation. The dataset to
be generated by this prospective study will be the empirical basis for follow on technology development in AI/ML
predictive analytics. Commercialization of the platform deployed within the current proposal represents a turn-
key software product that integrates multiple sources of information to enable clinicians to plan neurosurgery
more effectively in support of the best postoperative quality-of-life.
This application requests supplemental TABA funding to provide marketing and labeling guidance as
well as regulatory support to prepare and submit the FDA 510(k) premarket notification for MindTrace’s
platform. As an early-stage startup, our regulatory budget is limited. TABA funds are requested to allow us to:
1) produce and compile product labeling and marketing materials for commercialization and 2) prepare and
submit a 510(k) premarket notification. Support for these filings will likely increase the value of our enterprise.

Public health relevance
NARRATIVE MindTrace Technologies, Inc. is developing a cloud-based software platform to be used before, during, and after a neurosurgical procedure to generate evidence that can support the ability of surgeons to remove brain tumors while minimizing damage to critical brain regions that support everyday abilities, like talking, moving, and seeing. This supplemental TABA application seeks additional support to produce high-quality marketing and labeling materials as well as further develop a successful regulatory strategy.